Stroke Imaging of Conscious Rats

DESCRIPTION (provided by applicant): This proposal is a competitive renewal of R01NS045879 Stroke Imaging of Conscious Rats. In the previous grant cycle, we reported over two dozen peer-reviewed publications and leveraged multiple foundation grants to expand stroke research. Stroke remains to be the third leading cause of death and the leading cause of long-term disability. Our previous goals were to establish a rat stroke model with reproducible perfusion-diffusion mismatch (which approximates the ischemic penumbra), and to develop and apply quantitative perfusion, diffusion MRI and analysis methods to characterize pixel-by-pixel the spatiotemporal progression of diffusion and perfusion characteristics under different middle cerebral artery occlusion (MCAO) durations in the acute phase. Imaging measures were compared with histology. Gratifying progress was made on all previously proposed aims. In this competitive renewal, we seek to develop novel multimodal MRI approaches to probe the physiological and functional characteristics of the ischemic tissue at risk in stroke rats. These studies will focus on using blood-oxygenation-level dependent (BOLD) and cerebral blood flow (CBF) fMRI of physiologic (hypercapnic and oxygen) challenge and functional (stimulation and resting state) activity to probe perfusion and diffusion abnormality at 7 Tesla. We aim to apply these methodologies to study both acute and chronic stroke. Together, through an artificial neural-network predictive model, we will examine different MRI measures to accurately predict acute infarction and chronic recovery. Our central hypothesis is - through improved understanding of the physiological and functional profiles of ischemic tissue at risk and their spatiotemporal characteristics - tissue viability and functional recovery can be accurately predicted using only acute MRI data.

Public health relevance
PUBLIC HEALTH RELEVANCE: This proposal aims to develop novel multimodal MRI approaches to probe the "physiological" and "functional" characteristics of the ischemic tissue at risk in stroke rats. These non-invasive translational methodologies will provide a comprehensive anatomical, physiological and functional profile of ischemic tissue at risk and their spatiotemporal characteristics in a reproducible rat stroke model. These findings have the potential to positively impact stroke research, including testing of novel therapeutic strategies, as well as enhance clinical decision making in the treatment of acute stroke. NARRATIVE This proposal aims to develop novel multimodal MRI approaches to probe the "physiological" and "functional" characteristics of the ischemic tissue at risk in stroke rats. These non-invasive translational methodologies will provide a comprehensive anatomical, physiological and functional profile of ischemic tissue at risk and their spatiotemporal characteristics in a reproducible rat stroke model. These findings have the potential to positively impact stroke research, including testing of novel therapeutic strategies, as well as enhance clinical decision making in the treatment of acute stroke. __SpecificAimsTextDelimiter__ SPECIFIC AIMS This proposal is a competitive renewal of R01NS045879 "Stroke Imaging of Conscious Rats." In the previous grant cycle, we reported over two dozen peer-reviewed publications and leveraged multiple foundation grants to expand stroke research. Stroke remains to be the third leading cause of death and the leading cause of long-term disability. Our previous goals were to establish a rat stroke model with reproducible perfusion-diffusion mismatch (which approximates the ischemic penumbra), and to develop and apply quantitative perfusion, diffusion MRI and analysis methods to characterize pixel-by-pixel the spatiotemporal progression of diffusion and perfusion characteristics under different middle cerebral artery occlusion (MCAO) durations in the acute phase. Imaging measures were compared with histology. Gratifying progress was made on all previously proposed aims. In this competitive renewal, we seek to develop novel multimodal MRI approaches to probe the "physiological" and "functional" characteristics of the ischemic tissue at risk in stroke rats. These studies will focus on using blood-oxygenation-level dependent (BOLD) and cerebral blood flow (CBF) fMRI of physiologic (hypercapnic and oxygen) challenge and functional (stimulation and resting state) activity to probe perfusion and diffusion abnormality at 7 Tesla. We aim to apply these methodologies to study both acute and chronic stroke. Together, through an artificial neural-network predictive model, we will examine different MRI measures to accurately predict acute infarction and chronic recovery. Our central hypothesis is - through improved understanding of the physiological and functional profiles of ischemic tissue at risk and their spatiotemporal characteristics - tissue viability and functional recovery can be accurately predicted using only acute MRI data. Aim 1: Probing tissue viability of acute stroke using multimodal MRI This aim will probe tissue viability by using fMRI of: i) physiologic (hypercapnic and oxygen) and ii) functional (stimulation and resting state) response profiles. Perfusion, diffusion, T2 MRI, BOLD and CBF fMRI will be performed at 1, 2, 3 and 4 hours, and again 48 hours post-stroke in anesthetized rats subjected to different (30-min, 60-min, 90-min, and permanent) MCAO durations. Comparison will be made with behavioral tests and infarct volume. The following hypotheses will be tested: i. Hypercapnic challenge (HC) fMRI will provide an index of "vascular health." Tissue without HC fMRI response is indicative of vascular dysfunction. Oxygen challenge (OC) fMRI will provide a "physiologic/metabolic" index that will accurately define tissue salvageability. Tissue without OC BOLD response is non-salvageable whereas tissue with significant or above normal OC fMRI response is mostly salvageable. ii. Somatosensory stimulation fMRI will provide an index of functional viability, complementing the vascular health index. Tissue without forepaw and hindpaw stimulation responses is indicative of dysfunction whereas the presence of fMRI responses is indicative of functional viability. Resting-state (rs) fMRI will map disruption of functional connections without external stimuli. Normal, at- risk and ischemic-core exhibit unique rsfMRI profiles and they predict ischemic tissue fate. Peri-infarct spreading depolarization as detected by rsfMRI will positively correlate poor outcome. Through the artificial neural-network prediction model, we will examine how different MRI measures contribute to prediction accuracy, and determine the best and minimal combination of acute MRI measures that most accurately predict acute infarct. The temporal progression of different MRI measures will also be included in the prediction. We will test the hypothesis that incorporating multi-parametric profiles and their temporal characteristics will improve prediction accuracy compared with those by commonly used diffusion and/or perfusion data alone. Aim 2: Probing functional recovery in chronic stroke using multimodal MRI Paralleling Aim 1, this aim will use the above-described methodologies to study chronic stroke. MRI will be performed once after MCAO, once after reperfusion, and again on Day 2, 7, 21 and 30 in rats subjected to 30-min, 60-min, and 90-min MCAO. Comparison will be made with behavioral tests and infarct volume. Similarly, through the artificial neural-network predictive model, we will examine how different MRI measures contribute to prediction accuracy in chronic stroke. We will test the hypothesis that acute and chronic multi-parametric profiles and their temporal characteristics can accurately predict functional recovery. These non-invasive translational methodologies will provide a comprehensive anatomical, physiological and functional profile of ischemic tissue at risk and their spatiotemporal characteristics in a reproducible rat stroke model. These findings have the potential to positively impact stroke research, including testing of novel therapeutic strategies, as well as enhance clinical decision making in the treatment of acute stroke.